Defining Microbial and Host Factors in Innate Immune Responses in Lyme Arthritis

DESCRIPTION (provided by applicant): Lyme disease has reached epidemic proportions and continues to spread in certain locations in the northeastern U.S. This region is affected by an especially inflammatory B. burgdorferi genotype, RST1 (OspC Type A) which has been shown to have a high transmission frequency among ticks, and may be primarily responsible for the emergence of Lyme disease in epidemic form in the northeastern U.S. in the late 20th century. However, B. burgdorferi spirochetes do not contain any known toxins that cause virulence. Rather, the disease that ensues following infection is related to the type of inflammatory immune responses that are stimulated by the spirochetes, and that are further augmented by a single nucleotide polymorphism in the TLR1 (1805GG) gene which is present in about half of the European Caucasians. To assess the role of these microbial and host factors in innate immune responses in Lyme arthritis we propose: 1. to compare cytokine and chemokine responses in macrophages, a single cell type, from normal donors with or without the 1805GG polymorphism, stimulated with a highly inflammatory RST1 (OspC type A) strain or a less inflammatory RST2 (OspC type K) strain, using bead-based Luminex assays, 2. to identify the signal transduction networks used by macrophages to sense and respond to OspC type A or K strains and to assess how the 1805GG TLR1 polymorphism alters these networks, by measuring the activation of cellular genes using genome-wide microarrays, and 3. to discern the functional consequences of pathways identified by gene microarrays using RNA interference reagents to inhibit candidate genes by which the TLR1 1805GG polymorphism alters the inflammatory response in our macrophage culture system. Antibiotic-refractory Lyme arthritis may be, at least in part, a syndrome of inappropriate macrophage activation involving both microbial and host genetics. Macrophages are also implicated in the pathogenesis of other rheumatic diseases including RA in which the synovial lesions are similar to those in patients with antibiotic-refractory Lyme arthritis. Thus, it is likely that the targeted approach developed here, to delineate mechanisms underlying inappropriate macrophage activation in antibiotic-refractory Lyme arthritis, will be valuable in understanding how innate immune inflammatory responses may lead to development of autoimmunity in the joint in other inflammatory and rheumatic diseases, including RA.

Public health relevance
PUBLIC HEALTH RELEVANCE: The studies proposed here are aimed at delineating how specific host and pathogen interactions elicit the type of inflammatory innate immune responses that shape the development of putative autoimmune phenomena and lead to more severe disease. We believe the novel, discovery- based approach used in the proposal will provide important new insight into the pathogenesis of antibiotic-refractory Lyme arthritis and will likely be of significant clinical relevance to other forms of chronic inflammatory arthritis particularly those in which infectious agents and inappropriate innate immune system activation may play a role. __SpecificAimsTextDelimiter__ Defining Microbial and Host Factors in Innate Immune Responses in Lyme Arthritis. SPECIFIC AIMS Lyme arthritis is one of the few forms of chronic inflammatory arthritis in which the triggering cause is known with certainty, infection with the tick-borne spirochete Borrelia burgdorferi. Most patients with Lyme arthritis respond to antibiotic therapy. However, in a small percentage of patients, joint inflammation persists despite apparent spirochetal killing with 2-3 months of oral and IV antibiotics, called antibiotic-refractory Lyme arthritis. We have postulated that autoimmunity may play a role in this disease course. Thus, antibiotic-refractory arthritis is a unique human model to study infection and immunity in chronic inflammatory arthritis. We have identified both host and microbial factors associated with the development of antibiotic-refractory arthritis. We recently showed that B. burgdorferi genotypes vary in inflammatory potential. RST1 (OspC type A) strains stimulated macrophages to secrete significantly greater amounts of cytokines and chemokines than RST2 (OspC type K) strains, and RST1-infected patients had more frequent antibiotic-refractory arthritis. OspC types A and K are the 2 most common B. burgdorferi genotypes accounting for ~60% of Lyme disease cases. In addition, we recently showed that patients with a Toll-like receptor 1 (TLR1) polymorphism (1805GG), which is found in about half of the Caucasian population, are the most susceptible to the greater inflammatory potential of B. burgdorferi RST1 strains. This polymorphism in RST1- infected patients was associated with stronger innate and adaptive immune responses, with especially high levels of IFNγ, CXCL9 and CXCL10, more symptomatic early infection, and antibiotic-refractory arthritis. Thus, RST1 infection in patients with TLR1 1805GG seems to be important in setting the stage for putative autoimmunity and antibiotic-refractory Lyme arthritis. When stimulated with Pam3CSK4, the specific agonist for the TLR1/TLR2 heterodimer, the thymidine-to-guanine transversion at position 1805 in the TLR1 gene, which changes the amino acid at position 602 from an isoleucine to a serine in the transmembrane domain, leads to decreased numbers of TLR1 receptors on the cell surface, impaired down-stream signaling, and less cytokine production. In contrast, with B. burgdorferi RST1 infection, most cytokines and chemokines are induced at higher levels in the 1805GG group than in the 1805TG/TT group. Thus, we postulate that B. burgdorferi stimulates multiple pathogen recognition receptors, and a deficiency in the TLR1 receptor leads to the loss of a balancing anti- inflammatory signal, resulting in heightened innate and TH1-like adaptive immune responses. Because we think that macrophages would reflect the changes resulting from TLR1 1805GG, we propose here to use a macrophage cell culture system to dissect the molecular and cellular events that lead to this host immune response. Our specific aims are as follows: 1. To define the model system by comparing cytokine and chemokine responses in macrophages, a single cell type, from normal donors with or without the 1805GG polymorphism, stimulated with a highly inflammatory RST1 (OspC type A) strain or a less inflammatory RST2 (OspC type K) strain, using bead-based Luminex assays. 2. To identify the signal transduction networks used by macrophages to sense and respond to OspC type A or K strains and to assess how the 1805GG TLR1 polymorphism alters these networks, by measuring the activation of cellular genes using genome-wide microarrays. 3. To discern the functional consequences of pathways identified by gene microarrays using RNA interference reagents to inhibit candidate genes by which the TLR1 1805GG polymorphism alters the inflammatory response in our macrophage culture system.